Developmental Research Program

DEVELOPMENTAL RESEARCH PROGRAM: PROJECT SUMMARY
The primary goal of the Yale SPORE in Skin Cancer Developmental Research Program (DRP) is to provide
limited support (maximum of $50,000/year, typically for no more than two years) for a broad spectrum of
innovative skin cancer pilot projects (involving research, resources, and technology development applicable to
human skin cancer risk, prevention, diagnosis, prognosis, or treatment). These pilot projects must have
promising translational research potential, with anticipation that they can eventually develop into, or be
incorporated into, full projects with an unequivocal clinical translational component. Such projects could either
be developed into independent external funding at a scope and scale equivalent to a NIH R01 grant, or
alternatively augment or replace a Project in future cycles of the Yale SPORE in Skin Cancer. A total of at least
$230,000/year will be used for Developmental Research Projects ($56,262 in direct costs and at least
$173,738 in institutional matching funds guaranteed by the Yale Cancer Center and the Department of
Dermatology). These funds will make it possible to support up to five DRP projects annually, ranging from
$30,000 to $50,000 each. A second goal of this DRP is broaden the collective of Yale investigators who are
actively engaged in research related to human cutaneous oncology. During its second five-year funding period,
the YSPORE DRP has funded 22 different projects (20 related to melanoma, one to cutaneous T cell
lymphoma, one to keratoacanthoma) involving 28 different investigators from 15 different departments and
sections at Yale, and two outside institutions. Six of the projects involved multiple PIs and encompassed
multidisciplinary activities.

Public health relevance
DEVELOPMENTAL RESEARCH PROGRAM: PROJECT NARRATIVE The Developmental Research Program is an essential part of the Yale SPORE in Skin Cancer. DRP funding enables SPORE faculty to begin innovative and even risky high-gain research projects that promote understanding and clinical management of human skin cancers. Funding through the DRP mechanism enables evaluation of these novel ideas and yields experimental findings that will support further investigational development as formal SPORE research projects or with funding from NIH and private sources.